Optimization of Small Molecule GPR17 Antagonists for Multiple Sclerosis

Project Summary: The goal of this R03 proposal is to develop potent, selective antagonists for the orphan
receptor GPR17. Ultimately, ligands developed under this application will serve as tools to probe signaling
mechanisms and in vivo functions, and could expedite development of novel therapies for diseases potentially
mediated by GPR17, such as Multiple Sclerosis (MS). MS is a severe neurological disease characterized by
autoimmune-mediated demyelination of neurons and oligodendrocyte damage. The resulting axonal
degeneration impairs rapid nerve conduction, which leads to neurological disability if not repaired through
remyelination. The remyelination process requires proliferation and maturation of oligodendrocyte precursor cells
(OPCs) into myelin producing mature oligodendrocytes. GPR17 is an orphan GPCR that has been identified as
a negative regulator of oligodendrocyte maturation and is predominantly expressed in OPCs. GPR17-/- mice have
increased CNS myelination and GPR17 overexpressing mice showed lack of myelin sheath formation in the
CNS, similar to that seen in myelinating disorders. Addition of the GPR17 agonist probe MDL29,951 to cultures
from GPR17+/- mice resulted in reduced differentiation of oligodendrocytes, along with a decrease in myelin basic
protein (MBP) and dendrite formation. In addition, studies using an MS mouse model (experimental autoimmune
encephalomyelitis, EAE) showed an upregulation of GPR17 in CNS regions where demyelination was occurring.
Collectively, these data suggest the involvement of GPR17 in CNS demyelination upon activation. Hence, novel
small molecule antagonists that can selectively modulate GPR17 functions will be invaluable tools to study
GPR17 biology and lead to new drug discovery opportunities to treat severe demyelinating diseases such as
MS.
To date, very few small molecule antagonists have been reported in the literature and pharmacological
studies with the existing non-selective and less potent antagonists have been challenging. Our preliminary work
led to the identification of a novel small molecule lead compound SN-50 (GPR17 IC50 = 1701 nM, CysLT1, IC50
= 6580 nM) through structural modification of Pranlukast, a non-selective GPR17 antagonist (GPR17 IC50 = 588
nM, CysLT1 IC50 = 4 nM). SN-50 exhibited ~3- and 1600-fold reduced potency at GPR17 and CysLT1
respectively, and is ~4-fold selective for GPR17 over CysLT1. Moreover, SN-50 exhibits ~6-fold improved
selectivity compared to our previous lead SN-23 (GPR17 IC50 = 1035 nM, CysLT1, IC50 = 590 nM), which
promoted oligodendrocyte differentiation upon evaluation in a rat OPC differentiation assay. SN-50 therefore
serves as an excellent lead to identify potent and selective GPR17 antagonists. In Specific Aim 1 of the proposed
R03 project, we will synthesize at least 100 novel SN-50 analogs through a series of iterative scaffold
modifications. In Specific Aim 2, we will evaluate the synthesized compounds for GPR17 potency and selectivity
over CysLT1. Preliminary ADME properties of two lead compounds with favorable antagonist potency and
selectivity (GPR17 IC50 < 100 nM, >50-fold selectivity over CysLT1) will also be evaluated. These Aims will be
accomplished through a collaboration of chemistry and in vitro pharmacology.

Public health relevance
PROJECT NARRATIVE This program will provide novel, selective small molecule antagonists of the GPR17 receptor. These compounds will be invaluable tools to study unknown GPR17 biology and lead to new drug discovery opportunities to treat severe demyelinating diseases such as MS.